BONE GROWTH, PERIOSTEAL MIGRATION AND MUSCLE FUNCTION

The overall goal is to understand the influence of masticatory muscle function on the growth and ultimate morphology of the head. This project continues to characterize the properties of the masseter muscle-zygomatic arch complex in pigs, and to relate them to growth. Aim 1 is to determine whether tendon growth is determined by muscle force by analyzing the growth of the external aponeurosis of the masseter in relation to muscle pull. Aim 2 asks whether bony apposition can cause the periosteum to grow unevenly. Implants will be placed in bone, periosteum and muscle, and serial x-rays taken to show their growth distortions. Guinea pigs and ferrets will be used for study of the angle and the sagittal crest, respectively. Aim 3 is directed at understanding the "reversed strain pattern" observed in the zygomatic arch when the opposite masseter contracts; strain gages will be attached to various cranial bones and bone strain recorded to see whether the pattern is produced by the muscle directly, by loading the jaw joint, or by twisting the skull. Aim 4 addresses the problem of how the zygomatic suture affects stress transmission by investigating the physical properties of the arch and by studying how strain patterns are modified when the suture is fused experimentally or naturally. Aim 5 will use a specially designed pressure transducer to measure muscle forces normal to the bone surface, a direction not amenable to strain gage recording. Aim 6 focuses on the role of the periosteum in mediating muscle loads on bone. In addition to mechanical testing, the deformation of the zygomatic periosteum caused by masseter contraction will be measured. Aim 7 is to test the hypothesis that bony apposition occurs along the lines of tensile strain. One experiment will alter the masseter's line of action; another will modify skull growth using a bite-opening appliance. The general principles of how the tendons and bones grow in response to loads, of how muscle loads reach bone through the periosteum, and of how sutures either transmit or damp cranial stress, will be applicable to human growth and function at all levels. The specific findings pertain to clinical problems related to abnormal biomechanical effects, such as facial deformities, consequences of myopathies, and predicting the results of orthognathic surgery.